Efficacy of Antibiotic Treatment in the USAMRIID Model of Pneumonic Plague in African Green Monkeys (AGMs)

This interagency agreement will support GLP studies using the AGM model of infection to examine the utility of doxycycline as an oral post-exposure prophylactic for Pneumonic Plague, and as an oral or intravenous treatment.